Kidney targeted AAV for gene therapy

The kidney remains understudied as a target organ for in vivo gene transfer leading to a lack of effective gene
therapies for kidney disease. Chronic kidney disease (CKD) is estimated to affect 13% of the
population worldwide with high mortality and morbidity rates. Many kidney diseases have underlying genetic
etiologies that may be amenable by gene therapy or genome editing, underscoring the crucial unmet need
for effective and safe kidney-targeting gene delivery vehicles. Cystinuria is a common kidney inborn error
of metabolism with existing mouse and canine models providing an ideal disease model for preclinical gene
replacement strategies. With the approval of five AAV-based products by the FDA for treating ocular,
hematological and neuromuscular disorders, there ~200 completed or active gene therapy trials. However,
little progress has been made to date in achieving effective therapeutic gene transfer to kidneys due to the
intrinsic filtering function, diverse cell types, complex physiology, and species differences. We have recently
demonstrated successful evolution of cross-species compatible AAV capsids. The approach involves iterative
evolution in multiple animal models and such new AAV variants could enable better predictive preclinical
modeling and improve the therapeutic window of AAV gene therapies in humans. Here, we present
promising preliminary results successfully adapting this robust approach to tackle the problem of efficient
gene transfer to the kidney in multiple species. The current proposal hinges on understanding the biology of
new AAVs in kidney cell types and further engineering features that can improve kidney tropism and decrease
liver sequestration, thereby improving kidney targeting and safety (Aim 1). We will also develop these new
kidney-tropic AAV vectors for gene transfer to phenotypically correct cystinuria in in vivo mouse models and
human kidney organoid models (Aim 2). Using a battery of assays, we will evaluate the ability of gene transfer
to prevent disease onset as well as treat the disease phenotype in mouse models. We will also evaluate the
ability of new AAV variants and optimized vector cassettes to correct the cystinuria disease phenotype in
human induced pluripotent stem cell (hiPSC) derived kidney organoids. Overall, this collaborative proposal
between Vanderbilt University Medical Center and Duke University has the potential to be transformative for
gene therapy of kidney disorders.

Public health relevance
Gene delivery to the kidney has proven difficult, limiting the translation of genetic medicines to over 13% of the global population suffering from chronic kidney disease. The current proposal focuses on studying the biology of AAV vectors in the kidney and evolving kidney-targeted and liver de-targeted vectors for kidney gene therapy. A specific application of this proposal involves development and optimization of gene replacement strategies for treatment of cystinuria in relevant mouse models,